PROX1-dependent epigenetic regulation of phenotypic plasticity during colorectal cancer metastasis

PROJECT SUMMARY
Metastasis is the leading cause of solid tumor-associated death, yet our understanding of how metastasis
initiating cells acquire the capacity to and colonize distant organs has remained limited, hampering
development of effective treatment strategies. Large genome sequencing efforts have failed to identify
metastasis-specific driver mutations in colorectal cancer (CRC), suggesting that non-genetic phenotypic
plasticity is a unique feature of metastasis. We have developed an u biospecimen platform of surgically
resected patient normal colon, primary CRC and metastatic tumors from 31 patients, profiled with single cell
RNA-sequencing (scRNA-seq) and processed for organoid derivation for functional studies. We show that
metastatic evolution across patients is characterized by reprogramming into a conserved fetal intestinal state,
followed by lineage transdifferentiation into non-canonical squamous and neuroendocrine cell states that are
associated with therapy resistance in patients. My preliminary data demonstrate PROX1, a transcriptional co-
repressor upregulated in the fetal intestinal state, is an enforcer of intestinal lineage identity in primary tumor
organoids, and its functional loss de-represses non-canonical programs during metastasis. Furthermore,
PROX1 has been described to interact with subunits of nucleosome remodeling and deacetylase (NuRD)
complex (LSD1 and HDAC1/2) in primary CRC to repress gene programs through epigenetic mechanisms;
however, this level epigenetic regulation has yet to be explored in CRC metastasis. I hypothesize that PROX1
constrains intestinal lineage identity in CRC through repressive epigenetic mechanisms through the NuRD
complex, while PROX1 dysregulation in metastasis licenses non-canonical lineage expression. I have
successfully generated matched organoid pairs modified to downregulate or overexpress PROX1 to assess
how PROX1 perturbation differentially alters the transcriptional and epigenetic landscape of primary and
metastasis-derived organoids. In Aim 1, I will leverage these matched organoid pairs to assess how PROX1
perturbation differentially alters the transcriptional landscape of primary and metastasis-derived organoids in vitro
and in vivo through mouse orthotopic intrahepatic xenograft assays. In Aim 2, I will determine the PROX1-
dependent epigenetic mechanisms that restrict non-canonical differentiation and enforce intestinal lineage
identity through PROX1 and NurD subunit ChIP-seq studies and chromatin landscape characterization with
PROX1 perturbation. I will validate NuRD subunit interaction essentiality in enforcing a transcriptional
repression through pharmacologic inhibition studies in the context of PROX1-proficient organoids. Addressing
these gaps in our knowledge is of significant clinical importance will aid our understanding of metastasis to
inform the development of novel treatment strategies. The work and training plan outlined in this proposal will
be completed in the laboratory of Dr. Karuna Ganesh with the co-advisement of Dr. Scott Lowe at Memorial
Sloan Kettering Cancer Center and will prepare me for a career as an independent physician-scientist.

Public health relevance
PROJECT NARRATIVE Metastasis causes death by acquiring the unique ability to disseminate from a primary tumor and to adapt to foreign microenvironments. In colorectal cancer (CRC) and other solid cancers, metastatic progression is characterized by dedifferentiation into more primitive fetal states preceding a gain in phenotypic plasticity and the emergence of transdifferentiated cell states. The goal of this proposal is to test the hypothesis that PROX1, a transcriptional co-repressor aberrantly expressed during fetal reversion in CRC, modulates transcriptional and epigenetic programs that license phenotypic plasticity in metastasis.